Mechanisms of Cognitive Impairment Following Early-Life Seizures

Project Summary
Epilepsy is a complex disorder which involves much more than seizures. As emphasized by the National
Academy of Science-sponsored Committee on the Public Health Dimensions of the Epilepsies,1 epilepsy may
be accompanied by a range of associated co-morbid health conditions that can have significant health and
quality of life implications. Of these comorbidities, cognitive impairment is one of the most common and
distressing aspects of epilepsy. Because the risk of cognitive impairment is greatest in young children, the
educational, vocational, social and economic implications are enormous. Remarkably, there are only a handful
of laboratories attempting to understand the pathophysiological basis of cognitive disturbances in early-life
seizures (ELS). It is the view of our laboratory that prior to preventing, limiting and reversing cognitive
comorbidities, it is essential to understand the neurobiological basis of developmental cognitive dysfunction
associated with ELS. One of the major difficulties in decoding the complex issue of cognitive outcomes
following ELS in children is the gulf between the behavioral/mental spheres in which these deficits are
substantiated and the underlying physiological/developmental domains that are both the cause of these deficits
and the most likely domains for therapy and intervention. Based on strong preliminary data showing
abnormalities in rate and temporal coding in cognitive impairment following ELS, we propose that aberrant
neural circuit dynamics are the neurophysiological underpinnings of cognitive impairment. In this proposal, we
wish to rigorously study the consequences of ELS on temporal coding using multi-site single cell and local field
potentials. To move from correlative to causal experimentation, we will first determine if cognitive rehabilitation
following ELS reverses coding abnormalities. Secondly, we will use optogenetic-induced modulation of
neuronal circuits to modify coding abnormalities and correct spatial cognitive deficits. Based on compelling
preliminary data, we believe our findings will support the concept of dynamic neural discoordination as a causal
factor of cognitive dysfunction following ELS.

Public health relevance
Project Narrative Although seizures are the most striking clinical manifestation of the epilepsies, children with epilepsy are also at risk for a myriad of co-morbid health problems, including cognitive abnormalities, which are among the most common and troublesome. One of the major difficulties in deciphering the complex issue of cognitive outcomes following early-life seizures (ELS) in children is the gulf between the behavioral/mental spheres in which these deficits are substantiated and the underlying physiological/developmental domains that are both the cause of these deficits as well as the most likely domains for therapy and intervention. We contend that ELS result in spatial and temporal coding of action potentials which results, in turn, in neural discoordination. In this proposal we will evaluate the effect of ELS on neuronal coding and develop strategies to reverse neural discoordination and correct cognitive deficits.